The Synthesis of Bioactive Natural Products as a Driving Force for Discovery in Organic Chemistry

Project Summery
Equipment supplement – same as the parent grant

Public health relevance
Narrative Equipment supplement – same as the parent grant